Using a community-engaged approach to design and pilot-test an intervention aimed at reducing ultra-processed food consumption in preschool children to improve cardiovascular health

PROJECT SUMMARY
In the United States, cardiovascular diseases (CVDs) are the leading cause of mortality, responsible for one in
four deaths. While CVD typically manifests during adulthood, its risk factors -including obesity, lipid
abnormalities, and subclinical atherosclerosis- begin to develop in early childhood. A significant contributor to
these cardiovascular risk factors is the consumption of ultra-processed foods (UPF, foods made using
industrial processing methods with added ingredients such as sugar, salt, fat, and food additives). The
consumption and availability of UPF in children is alarmingly high providing 66% of the total energy intake
among 2- to 5-year-old children in the U.S., and 70% of foods purchased in the U.S. market for babies or
toddlers contain at least one food additive. Although there is substantial evidence of the cardiometabolic
effects of UPF consumption in adults, there is a need for evidence of the effect of UPF in young children.
Additionally, there is a critical need to identify interventions that can reduce UPF consumption in young
children. The focus of this study is on toddlers (2-3 years old), as this is a critical age when children’s food
preferences and long-term eating habits begin to develop. Establishing eating behaviors at this early age is a
promising approach to improving diet quality and reducing cardiometabolic risk. The goal of this proposed
research is to use a community-engaged approach to generate evidence of feasible and acceptable
interventions that reduce UPF consumption in toddlers (2-3 years old) to improve cardiovascular health. To
achieve this, I will 1) evaluate the association between UPF consumption and changes in adiposity,
cardiometabolic risk factors, and microbiome in toddlers, 2) identify barriers and facilitators to reducing UPF
consumption among parents of toddlers, and 3) pilot-test and evaluate a family-based intervention aimed at
reducing UPF consumption in toddlers. This research will help me to achieve my long-term goal of generating
robust evidence and partnering with communities and policy officials to co-design sustainable, rigorous, and
effective interventions to reduce health disparities and improve child health through nutrition. With the support
of this K01, I will build on my expertise in nutrition epidemiology and health policy nutrition, to gain training and
new skills in: 1) community-engaged research, 2) qualitative research methods, 3) Design, implementation,
and evaluation of clinical trials and longitudinal studies, and 4) Microbiome assessment and advanced
statistical methods for its analysis. I have the support of my institution and have assembled a group of highly
supportive mentors and advisors, who will provide me with the resources, expertise, and mentorship to
become an independent researcher and successfully compete for R01 funding.

Public health relevance
PROJECT NARRATIVE Cardiometabolic risk factors begin developing in early childhood, and the high consumption of ultra-processed foods (UPF) among young children is a significant contributor. This study aims to provide evidence on the association between UPF consumption and cardiometabolic risk factors in toddlers and, using a community- engaged approach, design and pilot test a family-based intervention. The results of this research will provide valuable evidence to support early interventions that improve diet quality, reduce cardiometabolic risk, and ultimately promote long-term cardiovascular health in children.